Flexible Steerable Laser Probe for Office-based Laryngeal Interventions

Project Summary/Abstract Benign lesions of the larynx affect 1 in 40 people at any given time, and treatment traditionally involves surgical excision in the operating room under general anesthesia. It is also possible to treat laryngeal lesions in the clinic, via the endoscopic application of laser energy. This approach is appealing because it can be simply performed in conscious patients with a topical anesthetic, has low complication rates, and has been shown to enable dramatic cost reductions when compared to surgical treatment in the operating room. Despite these beneﬁts, ofﬁce-based procedures are still underutilized because of how challenging they are to perform with available instrumentation. The laser ﬁbers used in these procedures lack distal articulation, which prevents physicians from treating disease in a number of hard-to-reach anatomical locations within the larynx. We propose to overcome these limitations by creating a new laser probe equipped with a distal articulation mechanism. This probe will be fabricated by combining a thin optical ﬁber with a steering sheath that will offer pan and tilt degrees of freedom to amplify a physician's reach during an ofﬁce-based procedure. The innovation of our device is twofold: (1) We will develop our steering laser probe in an ultra-thin diameter (s 1 mm). This is feasible because the steering sheath will be fabricated using an innovative ﬂexure-based approach where material is selectively removed from a tube of super-elastic Nitinol to create asymmetric notches. This enables articulation with a single pull-wire, enabling the sheath to be extremely thin. Nearly all other existing steering mechanisms are based on traditional mechanical joints (e.g. pin joints) which are difﬁcult to miniaturize and thus not straightforward to use in an endoscopic procedure. (2) We will replace the ﬁbers in clinical use today (0.4-0.6 mm core diameter) with thinner ones (0.32 mm and below) to enable further miniaturization. Use of ﬁbers with a 0.4-0.6 mm diameter core is required clinically to produce an adequate laser spot size for treatment. To reproduce the spot sizes produced by these ﬁbers in thinner-core ﬁbers, we will utilize an innovative ﬁber tapering technique where the geometry of the ﬁber tip is engineered to produce prescribed optical light emission characteristics. We will create and validate our steering laser probe via three Speciﬁc Aims. Aim 1 involves the design, fabrication, and testing of our novel ultra-thin steering sheath. In Aim 2 we will develop a custom optical laser ﬁber. Aim 3 addresses the validation of the laser probe prototype in cadaver specimens. The endpoint of this R15 will be proof-of-principle for our ultra-thin steering laser probe, together with a cadaver demonstration of how this instrument would be used in clinical practice.

Public health relevance
Project Narrative The objective of this project is to create the ﬁrst laser probe capable of controllable articulation for use in endoscopic laryngeal procedures. This research is motivated by the high prevalence of laryngeal pathology (1 in 40 people suffer from a benign laryngeal lesion at any given time) and the need for a non-surgical, cost-effective solution for the treatment of these conditions. Our new steerable laser probe will enable physicians to reach and treat anatomical locations that are normally inaccessible during ofﬁce procedures, and potentially spare many patients the need for expensive surgical treatment.